PHASE II TRIAL OF PSC833 WITH DOXORUBICIN IN PATIENTS WITH METASTATIC BREAST CA

The purpose of this study is to 1) see whether chemotherapy with PSC833 and doxorubicin (ADR) is effective in treating patients with breast cancer; 2) evaluate side effects; 3) study how p-glycoprotein interacts with PSC833 and ADR; and 4) determine how the body proccess both drugs.